Redox modulation - Impact on Tumor Growth and Therapeutic Anticancer Efficacy

Despite advances in cancer biology, drug resistance is a major obstacle to patients and clinicians. Many current cancer therapeutics work in part by elevating reactive oxygen species (ROS) production, often leading to tumor regression followed by tumor reoccurrence and therapeutic resistance. Previously, Kelkka and coworkers looked at tumor progression in mice with macrophages deficient in ROS from the protein NOX2 (Kelkka et al., 2013). They concluded that immune cells are more efficacious against metastasis and tumor progression when ROS production in macrophages is inhibited. On the other hand, others have demonstrated the relationship between carcinogenesis and our innate antioxidant systems such as the thioredoxin reductase (TrxR) system and the glutathione reductase system (Gorrini et al., 2013). As carcinogenesis progress, cells produce increasing levels of ROS. Tumor cells cope with high levels ROS via an adaptive antioxidant response such as the thioredoxin reductase system. However, when this system is impaired within tumor cells, in vivo tumor progression and metastasis may be significantly inhibited (Yoo et al., 2006). Given these findings, we believe that tumor cells become resistant to current therapies in part by the systemic increase of ROS production, which 1) is insufficient to promote cell death in tumor cells because of their adaptive antioxidant response, and 2) elevated levels of ROS impairs immune cells from effectively combating tumor cells. Therefore we propose that a combined approach is required for effective anticancer therapy. We hypothesize that tumor cells with dysfunctional antioxidant systems will significantly regress and that the host’s immune response, under low ROS conditions, will be primed to eradicate the remaining malignancy. The focus of this proposed PhD project is to investigate this hypothesis and characterize the optimal Redox conditions for tumor regression. We plan to accomplish this using two well-established murine tumor models: 1) the metastatic B16F10 melanoma and 2) the metastatic Lewis Lung Carcinoma, LLC1. We will characterize in vitro the baseline Redox systems in these tumor models, make alterations using siRNA or CRISPR. We will also look at tumor progression in living hosts. We will use six mouse strains to help us understand the significance of host Redox biology, in both the immune cells and systemically, in response to cancer. Specifically, we will use mouse models with key phenotypes: B6.129P2-Txnrd1tm1Marc, B6.129P2-Txnrd1Cond, BQ.Ncf1m1J (Ncf1 mutant mice), BQ.Ncf4 (Ncf4 mutant mice), BQMN (expressing Ncf1 in macrophages only) and BQ.TN3 conditional knock-in mice. Finally, we will study tumor redox systems challenged with Auranofin and other TrxR1 inhibitors.

Public health relevance
The findings from this project would contribute to the fundamental understanding of oxidative-reductive (Redox) biology in living systems and when these systems are challenged with cancer. The findings have a potential to yield ground breaking insights into changes in Redox biology within living systems as 1) their cells transform from pre-malignant growths to malignant growths and 2) when these cells and hosts are challenged by anti- cancer therapies. Most importantly, the knowledge gained from this research project may be used to develop improved therapies for cancer patients.